Feasibility of Using Maestro Hand Exoskeleton in Post-stroke Hand Rehabilitation to Improve Joint Coordination

Estimated 15,000 Veterans suffer a stroke each year. Stroke is a leading cause of long-term disability in the US.
New strokes cost an estimated $111 million for acute inpatient care, $75 million for post-acute inpatient care,
and $88 million for follow-up care in the first six months post-stroke in VHA. Yet, more than two thirds of stroke
survivors have persistent hand impairment that significantly diminishes their abilities to perform activities of daily
living. While it is known that training for healthy movement patterns is critical especially early on in rehabilitation,
precise control of multiple finger joints simultaneously is not possible in current therapy. Controlling finger joint
movements is challenging since the human hand has more than 20 degrees of freedom (DOF) densely located
in a small space. There exist robots for hand rehabilitation that train for gross grasping and finger individuation.
However, current robots have limited DOF and cannot control finger joint torques, so these systems are unable
to deliver training that ensures healthy movement patterns. Thus, there is lack of tools for delivering training
that ensures healthy movement pattern and prevents compensatory movements. With a lack of joint-level training
tool, patients are either left with compensatory patterns, or worse, have no recovery of hand movements. With
the long-term goal of improving hand rehabilitation, we have designed a robotic tool called the Maestro hand
exoskeleton. Maestro’s design features enable delivery of versatile interventions for patients with a wide range
of impairments in various stages of recovery. This innovation represents a substantial advancement from current
rehabilitation robotic tools by providing high-intensity, task-based training with real time modulation of assistance
and difficulty level ensuring patient participation and task saliency. The objective of this project is to develop
novel controllers with promising neurological basis for training correct movement patterns in stroke patients.
Specifically, (1) compensation avoidance (CA) controller will apply joint torques to push the patients away from
the compensatory joint coordination, only interfering with the movements once the subject initiates a
compensatory movement strategy. (2) Task assistance (TA) controller will apply assistive joint torques to directly
help stroke patients achieve finger tasks with correct coordination. For both controllers, the torques in the finger
joints will be modulated to match the individual patient’s ability, impairment, and progression throughout the
training via robot control program. Four and nine Veteran subacute stroke survivors with moderate to severe hand
impairment and with some ability to move fingers will participate in the testing for Aim1 and Aim 2, respectively.
Aim 1 will involve one session and Aim 2 will involve four sessions of experimentation for each participant. Aim 1:
Develop and determine feasibility of CA and TA controllers. Hypothesis: CA and TA controllers are feasible, as
seen by (1) patient safety and (2) abilities for TA and CA controller to move the finger joints toward the desired
trajectories and away from compensatory coordination, respectively. Aim 2: Determine feasibility of training
using CA and TA controllers in subacute stroke. Hypothesis: Joint coordination will improve over a training
session more with CA controller for patients with moderate impairment, and more with TA controller for patients
with severe impairment. Impact: This research will develop a novel training tool to improve finger joint
coordination, thereby addressing the unmet need in the current rehabilitation. Future studies will use the
developed Maestro controllers to elucidate underlying principles of practice-related neuro-recovery post stroke
per impairment level and determine the effectiveness of Maestro on improving finger joint coordination and hand
function. As a result, this research is expected to enhance hand function, contributing to improved independence
and quality of life for Veterans with stroke.

Public health relevance
This research is relevant for Veterans, as stroke is one of the leading causes of long-term disability in Veterans. An estimated 15,000 Veterans suffer a stroke each year. A novel rehabilitation treatment option developed as a result of this research has the potential to reduce the consequences of stroke for Veterans. Therefore, the proposed research is expected to contribute to providing Veterans with better post-stroke rehabilitation care with improved performance for activities of daily living.